MT INBRE: A Multidisciplinary Research Network

Project Summary
Montana is a large state comprised of predominantly rural and tribal communities, which presents numerous
challenges to the development of integrated data science communities, shared research and training capacity,
and cyberinfrastructure. Here we outline a series of synergistic activities to develop shared instructional and
computational resources to support student training in data science, strengthen the state-wide data science
community, and foster research and training collaborations between research-intensive universities, Tribal
colleges, and other primarily undergraduate-serving institutions. These efforts will build on the comprehensive
five-year plan developed by the Montana IDeA Network of Biomedical Research Excellence (INBRE) program
to improve the health of rural, urban, and native Montanans through sustainable research and the development
of a diverse biomedical and health sciences workforce through student training in Montana. Aim 1 will build
new partnerships between the Montana INBRE data science team and educators at Salish Kootenai College
through collaborative on-site instructional activities that promote hands-on student training in bioinformatics
and genome sciences. We will also intensify our efforts to strengthen connections with the seven Tribal
colleges in Montana through site-visits to learn specific self-identified research and training needs and identify
emerging biomedical projects motivated by local expertise and interests. Aim 2 will reduce barriers to effective
data science education by developing modular training tutorials and focused workshops to establish
foundational skills in data science, genomics, informatics, and high-performance computing. Aim 3 will expand
computational infrastructure for Tribal colleges and primarily undergraduate-serving institutions by
implementing an intuitive, web-based interface (Open OnDemand) that eliminates the traditional barriers
associated with high-performance computing for researchers, teachers, and students. Finally, Aim 4 will work
to building diverse and connected data science communities and partnerships across Montana by hosting a
state-wide summit on data science and a workshop on the ethical and effective use of generative artificial
intelligence.

Public health relevance
Project Narrative This supplement to the Montana IDeA Network of Biomedical Research Excellence grant will support the development of data science educational and computer resources for students and researchers across the state. The proposed work will also use collaborative team-teaching efforts and workshops to foster connections between research-intensive universities, Tribal colleges, and other institutions that support undergraduate education in Montana. These efforts will strengthen the capacity for data-driven biomedical research and student training across tribal and rural communities of Montana.